Summer Research in Environmental Health Sciences

Abstract
The overall goal of this proposal is to develop and implement a 10-week summer program
(Summer Undergraduate Research in Environmental Health Sciences (SURES) that will
immerse upper-level undergraduates in environmental health science research. The program is
designed to introduce students to the highly interdisciplinary and collaborative nature of
environmental health science research that is focused on solving key global health problems.
An additional focus is preparing underprivileged and under-represented students for successful
careers in relevant fields. The SURES program will leverage the substantial and ongoing
efforts at the University of Kentucky driven to enhance the undergraduate experience with the
robust environmental health science research programs of involved faculty mentors. Students
will be recruited from the Commonwealth of Kentucky with an emphasis on those from the
Appalachian region. The SURES program will commence with a week-long session that
introduces students to research, laboratory safety and scientific ethics. The students will then
experience hands-on research by performing experiments in the laboratories of their chosen
mentors. Professional development and a sense of belonging to the environmental health
sciences community will be built via student participation in weekly breakfasts, lunches, net-
working opportunities, tours of research facilities and social activities including “movie nights”
where films depicting environmental issues will be viewed and discussed. The SURES program
will culminate in a poster session attended by the faculty, staff and students of the participating
departments. Dissemination of the approaches used in this program and their outcomes will
build upon the expansion of the traditional environmental health sciences research training from
the graduate and post-doctoral level to the undergraduates at a national level.

Public health relevance
Narrative The overall objective of the Summer Undergraduate Research Experience in Environmental Health Sciences (SURES) program is to develop a research-intensive program that will introduce students from the impoverished region of Appalachia to the multidisciplinary nature of environmental sciences and opportunities for pursuing relevant careers. The program will provide exceptional training in a wide variety of research areas working with interdisciplinary collaborative research groups who are housed in multiple departments and colleges. In addition, students will be engaged in seminars, outreach opportunities and workshops to prepare them for successful, environmental health related careers.